Administrative Core

Administrative Core Project Abstract
In this application we present a core scientific structure that is specifically designed to support scientific effort
along the overarching themes of prematurity prevention and advancing personalized medicine approaches to
IDD; for the latter, utilizing expertise in the elucidation of intermediate phenotypes, advancing characterization
of the developing human brain, and infrastructures for functional genomic studies. The Administrative Core
assumes responsibility for scientific oversight as an integrated Center that is a discovery pipeline for translational
advances in IDD research. The Specific Aims are: 1) To sustain an effective system of management of the day-
to-day operation of the Center’s funds and resources, which includes the efficient flow of necessary resources
to maintain three efficient, cost-effective, state-of-the-art core scientific facilities that constitute a critical
infrastructure for IDD research in the WUSTL environment: the Model Systems Core (MSC), the Developmental
Neuroimaging Core (DNC), and the Clinical-Translational Core (CTC); 2) To stimulate intramural and extramural
scientific collaboration and discovery along key frontiers of IDD research and 3) To disseminate new knowledge
and implement practice improvements that are based upon new discovery, through partnerships with the
University Centers of Excellence in Developmental Disabilities (UCEDDs), Leadership Education in
Neurodevelopmental Disabilities (LENDs), the Missouri Dept. of Mental Health, regional clinical providers, and
other external entities involved in the care of children and adults with developmental disabilities.